STudy of Acute HIV for investiGating Eradication Strategies (STAGES)

PROJECT SUMMARY/ ABSTRACT
The goal of HIV cure research is to induce “antiretroviral therapy (ART)-free” remission by eliminating persistent
HIV to overcome the need for lifelong ART and improve clinical outcomes associated with persistent HIV
(increased inflammation- and aging-associated diseases). However, HIV cure trials have thus far failed to
demonstrate a clinically meaningful reduction in the HIV reservoir size or lead to sustained ART-free viral control.
The goal of the proposed work is to address a critical need – to determine host in vivo mechanisms that drive
HIV reservoir decay and sustain long-term viral control, identifying potential novel therapeutic candidates for HIV
cure. We recently demonstrated that class II cytokines (specifically, IL-10 and type I and III interferons) exhibited
ongoing fluctuations and predicted faster HIV reservoir decay during the first 24 weeks of ART. These data
support prior work demonstrating a dynamic and temporal role of type I interferons in controlling HIV/SIV infection
and two recent studies that showed a critical role for IL-10 in the maintenance of the HIV/SIV reservoir. However,
these other studies did not specifically evaluate the role of host cellular drivers of class II cytokine-mediated viral
control across HIV stages: acute HIV infection (AHI), ART initiation (ARTi), ART suppression (ART+), and ART
interruption (ATI). Our central hypothesis is that class II cytokines dynamically control virus at different stages of
HIV. We aim to identify the host cellular drivers of class II cytokine-mediated viral control across HIV stages from
50 participants from our UCSF Treat Acute HIV cohort (diagnosed and initiated ART <100 days from infection),
which includes monthly biospecimen sampling as well as optional tissue sampling (gut, lymph node) and ATI
sub-studies. Host viral control will be measured as (1) HIV reservoir decay and (2) post-ATI control (time-to-viral-
rebound [TTVR]). Since there is no “gold standard” for measuring the HIV reservoir, we will leverage several HIV
reservoir assays currently being performed in our cohort, using additional funded grants. We hypothesize that
across longitudinal blood timepoints (Aim 1), class II cytokine-mediated cellular responses exert robust innate
antiviral effects (e.g., after HIV transmission), enhance adaptive/cell survival responses during long-term ART+,
and re-induce innate responses at ATI. We hypothesize that these cellular responses are more robust in tissues
than in blood (Aim 2) since several class II cytokines (IL-10, IFN λ/IL 29) act as antiviral defenses specifically at
mucosal barrier tissue sites. Finally, we hypothesize that plasma metabolic signatures will predict class II
cytokine-driven viral control, priming their use in future HIV cure clinical monitoring (Aim 3). Targeting class II
cytokines represents a promising interventional strategy, but given their complex host-viral temporal dynamics,
a deeper understanding of the natural timing, cellular drivers, and tissue-specificity of these cytokines is needed
to better inform future HIV cure trial design. By identifying the cellular drivers of class II cytokine-driven viral
control across stages of HIV, we expect that findings form this study can be applied/compared to other acute
HIV populations, as well as other class II cytokine-mediated diseases (e.g., cancer, autoimmune disorders).

Public health relevance
PROJECT NARRATIVE Despite nearly four decades of research, we still do not have an HIV cure or vaccine, and curative drug trials in people living with HIV (PLWH) have thus far had minimal impact on achieving a durable “antiretroviral therapy (ART)-free remission.” The goal of the proposed work is to address a critical need – to determine host mechanisms that “naturally” drive long-term HIV control throughout various stages of HIV, in order to identify potential novel future drug candidates for HIV cure. Based on our preliminary data, we hypothesize that specific antiviral cytokines (IL-10, interferons) dynamically control virus at different stages of HIV: acute HIV infection (AHI), ART initiation (ARTi), ART suppression (ART+), and ART interruption (ATI), and that findings from this study will help inform future HIV cure trial design as well as other class II cytokine-mediated diseases (e.g., cancer, autoimmune disorders).